MATERNAL ZINC STATUS DURING LACTATION GROWTH OF THE BREAST FED INFANT

To determine the effect of variations in maternal zinc intake, within the frame work of the recommended dietary allowance on maternal zinc status, milk zinc concentrations and infant growth.